VISUALIZATION OF QUANTITATIVE BIOLOGICAL MASS SPECTROMETRY DATA

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Visualization of Quantitative Mass Spectrometry data in the context of biological networks is a key to the development of biological hypothesis from proteomic data. We intend to use Cytoscape to visualize the quantitative MS data (SILAC, iTRAQ, D2O, etc, as well as SRM data) in the context of networks (GO, Protein-Protein Interaction, etc). Our intent is to begin with the more established quantitative Proteomic Methods via pilot projects such as the Burlingame-Wiezman Institute collaboration on wound healing project and eventually introduce data from Selected Reaction Monitoring (SRM). Once we are familiar with the process we intend to develop a plugin to aid in the importation of MS data from ProteinProspector thus providing better synergy between the two tools.